Purification and Characterization of a toxic AD associated intracellularly generated amyloid beta fragment

ABSTRACT
There are over 5 million cases of Alzheimer’s disease (AD) in the US, the number of cases is expected to nearly
double over the next 15 years, and the total annual economic costs are over $225 billion. Despite this, there is
still no effective treatment for AD. The protein amyloid-beta has long been linked to AD, but much confusion over
the role of amyloid-beta in AD still exists and therapeutics targeting amyloid-beta have had limited success.
Amyloid plaques are hallmark features of AD, but plaque loads do not correlate well with AD progression, and
studies suggest that oligomeric amyloid-beta forms rather than fibrillar forms are the relevant neurotoxic species
in AD. In vivo, amyloid-beta is a very heterogeneous protein, and many distinct monomeric and aggregated
variants are present in human AD brain. Since protein conformation is directly related to function, determining
the conformations of key Aβ variants is crucial to understanding their mechanistic roles in AD. However, the 3-
D structures of relevant oligomeric amyloid-beta variants involved in AD neurodegeneration remain elusive. This
is likely due to the fact that the different oligomeric amyloid-beta variants are present at only very low levels in
human AD samples making structural analysis difficult. The proposed research is focused directly on this
problem: here we will generate and characterize a key oligomeric amyloid-beta aggregates found in human AD
brain but not cognitively normal brain tissue using antibody derived tools (Fabs) generated in our lab. The C6T
Fab selectively recognizes a key intracellularly generated oligomeric aggregates of amyloid-beta that is present
in AD brain tissue but not tissue from cognitively normal age-matched control brain tissue. The C6T Fab will
serve as the foundation of the proposed research, which seeks to enable the complete structural and biochemical
characterization of the toxic oligomeric forms of amyloid-beta found in AD brain tissue. The C6T Fab will be used
to isolate the toxic intracellularly generated amyloid-beta variant via immunoprecipitation. Mass spectrometry will
then be used to determine the protein composition of the generated aggregates. Since the aggregates generated
from human brain tissue may be quite heterogeneous due to the extensive post-translational modifications of
amyloid-beta in human brain, we will also similarly isolate and characterize the toxic cell generated amyloid-beta
aggregate as generated in the mammalian cell line, 7PA2. These studies will provide the framework for further
3-D characterization studies of this key amyloid-beta variant. We have assembled a team with unique capabilities
in Fab development, 3-D structure determination and protein modeling to perform these studies. Structural
information of the different oligomeric amyloid-beta species will be vitally important to our understanding of how
they interact with different cellular targets and to help devise appropriate therapeutic strategies. These methods
could be easily applied to other key protein variants implicated in neurodegenerative diseases including tau,
alpha-synuclein and TDP-43.

Public health relevance
NARRATIVE Generation of toxic oligomeric beta-amyloid by neurons is considered to be a key step in the onset and progression of AD. This project will generate and purify a key oligomeric beta-amyloid variant that is present in human AD brain but not healthy controls and has been extensively documented as playing a key role in AD. The project has direct applications for determining not only the structure of this key beta-amyloid variant, but also of other toxic protein aggregates implicated in neurodegenerative diseases including tau, TDP-43 and alpha-synuclein.